SHIFT Onboard: Protecting New Transit Operators Against Safety and Health Hazards

PROJECT SUMMARY
Obesity is twice as prevalent among occupational drivers than in the general population. Obesity and
associated health conditions increase the risk of vehicle collisions and increase the costs and lost work time
associated with injuries by 80%. However, effective interventions are scarce. In our prior funding period we
demonstrated the efficacy of a weight loss intervention (tertiary prevention) named “Safety and Health
Involvement For Truckers” (SHIFT). Building on this success, we will advance the field further by adapting our
technology and tactics for primary prevention of weight gain among mass transit bus operators during their first
years of employment. Our competing renewal strategy will also advance organizational science by integrating
an effective health intervention with traditional new employee training and socialization processes. Fifty years
of epidemiological evidence is clear – bus driving increases the risk for obesity and health problems, and it is
time for interventions. Our preliminary data suggest that new drivers gain substantial weight during their first
year. Health disruptive transitions in early years, like long sedentary work hours, shift work, and stress, may
also impact costly problems of absenteeism and collisions in the transit industry. However, weight gain
prevention interventions are lacking for employees entering obesogenic occupations, and few workplace
training and socialization programs for new hires (referred to as onboarding) explicitly address health hazards.
Onboarding is a critical socialization process where employees acquire core skill competencies, establish
work-supportive social relationships, learn corporate values, and observe and adapt to workplace norms. Thus,
the potential for creating long-lasting impacts on both health and safety during this critical period is high. Our
effective SHIFT intervention is implemented through a mobile friendly website, and tactics include an
incentivized game-like competition that is supported with behavior and body weight logging, computer-based
training, and motivational interviewing. In our proposed adaptation “SHIFT Onboard” (Safety & Health Impact
For Transit drivers during Onboarding) will be designed to prevent weight gain among new bus drivers and
support their early adjustment and job success. Our primary hypotheses are that relative to usual practice,
SHIFT Onboard participants will have (1) superior sleep, eating, and exercise behaviors; and (2) less weight
gain. We will also evaluate impacts on new employee adjustment and economic outcomes that are critical to
employers; the ultimate adopters of occupational health innovations. Our ability to succeed is bolstered by our
unique past success with transportation workers, expertise in organizational onboarding, and strong transit
labor and management support. To test our hypotheses, we will conduct formative research followed by a
randomized controlled trial. Our 5-year plan will accomplish 3 specific aims: (1) Adapt our proven tactics and
pilot SHIFT Onboard for mass transit bus drivers; (2) Determine the efficacy of SHIFT Onboard for preventing
weight gain; and (3) Evaluate new employee adjustment and economic impacts of SHIFT Onboard.

Public health relevance
PROJECT NARRATIVE Obesity is twice as prevalent among occupational drivers than in the general population, but effective interventions remain scarce. In our original project we established the effectiveness of our SHIFT weight loss intervention for commercial truck drivers with a randomized controlled trial. Building on the successes of our previous work, we will advance the field further by adapting our technology and tactics for primary prevention of weight gain among mass transit bus operators during their first years of employment.!